Nutrition Obesity Research Center (NORC)

– Overall Component
MPI: Mayer-Davis, Elizabeth J and Shaikh, Saame R
Project Summary – Overall Component. The overarching theme of the Nutrition Obesity Research Center (NORC) at the University of North Carolina at Chapel Hill (UNC) is “Interdisciplinary Nutrition Research: From Molecules to Public Health.” The UNC NORC brings together community, population-based, clinical, and basic science investigators to increase the effectiveness of nutrition and obesity research. Truly innovative, high-impact research requires communication and collaboration of researchers along the continuum from basic science through clinical to public health research. To facilitate a bidirectional translational process, the UNC NORC created an infrastructure that makes it easy for investigators from different disciplines, who often speak different scientific “languages,” to share methods and ideas so they can solve problems relevant to nutrition and obesity using new perspectives derived from the interfaces of their disciplines. We include an Administrative Core and three biomedical research cores: the Genomics and Metabolic Phenotyping Core, the Clinical and Community Human Assessment and Interventions Core, and the Metabolomics and Proteomics Core are successful cores providing exceptional services to both UNC NORC members and external users across the nation. The UNC NORC Pilot and Feasibility Program successfully funds young investigators who were able to use this seed money to develop competitive NIH proposals, and the Enrichment Program disseminates the results of the UNC NORC’s members. Our record of success during the last funding period is substantial. The UNC NORC has 136 member scientists from 39 different departments and divisions of UNC. They have exceptional research funding, having been awarded $144.7 million in nutrition and obesity grant funding during the last five years. Of this total, 88% was from federal grants ($127 million) with $29.2 million from the NIDDK. Our research base members have an exceptional publication record, with 912 peer-reviewed publications that are directly related to the support they received from the UNC NORC. Maintaining research cores across a range of disciplines, the UNC NORC will continue to serve as an interdisciplinary research translation engine to advance nutrition and obesity research.

Public health relevance
Project Narrative – Overall Component. The Nutrition Obesity Research Center (NORC) at the University of North Carolina at Chapel Hill (UNC) takes as its central theme “Interdisciplinary Nutrition Research: From Molecules to Public Health.” We include an Administrative Core and three biomedical research cores: the Genomics and Metabolic Phenotyping Core, the Clinical and Community Human Assessment and Interventions Core, and the Metabolomics and Proteomics Core. As an integrated whole, the UNC NORC will provide the framework, tools, and expertise investigators need to engage in the interdisciplinary research required to improve health outcomes. Modified Project Summary/Abstract Section – Administrative Core MPI: Mayer-Davis, Elizabeth J and Shaikh, Saame R Project Summary – Administrative Core. The Administrative Core provides leadership, long-term direction, and financial management to allow the Nutrition Obesity Research Center (NORC) at the University of North Carolina at Chapel Hill (UNC) to enhance the nutrition and obesity research of the UNC NORC’s exceptional research base. Given the Center’s size and complexity, the Administrative Core is critical to coordinating and integrating UNC NORC activities and keeping the many components of the UNC NORC functioning optimally. The Core provides the needed infrastructure to UNC NORC members so that they can effectively compete for external funding. The Core plays an important role in coordination across the UNC NORC to ensure efficiency and to leverage opportunities for interdisciplinary work. The Core also facilitates the effective execution of the Pilot and Feasibility (P&F) Program and the Enrichment Program, including substantial efforts in nutrition education, notably for medical students and physicians at UNC and across the nation. Importantly, the Core facilitates and monitors accurate and appropriate allocation and collection of Center finances. In addition, the Core effectively presents the accomplishments of UNC NORC members to UNC administration such that University leadership has dramatically increased the investment of permanent State funds for nutrition and obesity research. The Directors of the Administrative Core, Drs. Elizabeth Mayer-Davis and Saame Raza Shaikh, are experienced administrators with demonstrated scientific and administrative leadership abilities. Drs. Mayer-Davis, Shaikh, and the Administrative Core oversee all UNC NORC research cores to ensure the productivity, effectiveness, and appropriateness of their activities. The Core recruits members for the research base and ensures their membership eligibility. The Core manages strategic planning by the Internal Advisory Committee and coordinates with the External Advisory Committee. The Administrative Core has demonstrated a strong record of success providing oversight to the UNC NORC and supporting an outstanding research base that successfully competed for $144.7 million in nutrition and obesity research funding and generated 912 high-quality publications. Modified Project Summary/Abstract Section – Genomics and Energy Metabolism Core PI: Voruganti, Venkata Saroja Project Summary – Genomics and Energy Metabolism Core. The UNC NORC Genomics and Energy Metabolism (GEM) Core provides critical infrastructure for genomic, microbiome, and metabolic phenotyping for members conducting research across a range of model systems from studies at the human level to animal and cellular models. The core is led by Dr. Saroja Voruganti, who has strong expertise in providing services related to a wide range of preclinical and clinical projects. Dr. Voruganti is supported by senior faculty with expertise in each of the GEM Core subcores, which are: Nutrigenomics (NGx), Microbiome, and Metabolic Phenotyping. The GEM Core provides scientific, technical, and interdisciplinary expertise and resources needed to advance nutrition and obesity research at UNC. The Core integrates with other NORC Cores to offer expertise in study design, technical expertise, and training activities. The Core extensively guides investigators through a well-defined workflow from study onset to study completion, ensuring strong rigor and reproducibility. In addition, the core ensures strong quality control of instrumentation. The GEM Core provides services on the Chapel Hill main campus at the UNC Nutrition Research Institute in Kannapolis, NC. Key services provided by the GEM Core are: DNA and RNA extraction from tissues, fecal metabolite assessment – as well as customized, cutting-edge research tools – including whole genome, exome, and targeted gene sequencing; RNA-sequencing; microbiota characterization, including 16S rRNA gene sequencing and shotgun metagenomics; targeted genotyping using PCR-based assays; array- based gene expression profiling; and bisulfide sequencing for methylation patterns in humans and mouse models. Furthermore, cutting edge resources are available for murine studies of energy balance and locomotor activity as well as metabolic phenotyping of live cells. Leveraging the resources available at the UNC NORC, the GEM Core fills a critical gap in nutrition and obesity research at UNC by providing investigators with the expertise and resources to investigate the role of host genetics, gut microbiome, and energy metabolism in response to nutritional exposures. Modified Project Summary/Abstract Section – Metabolomics and Proteomics Core PI: Herring, Laura E Project Summary – Metabolomics and Proteomics Core. The purpose of the Metabolomics and Proteomics (MAP) Core is to encourage and facilitate the use of targeted and untargeted analytical methods for nutritional epidemiological and intervention studies, to provide access to state-of-the-art techniques and equipment to bench scientists, and to provide cost-effective assays for investigators without lab facilities. The Core was established in 1999 under the leadership of Dr. Steven Zeisel. Dr. Susan Sumner joined UNC in 2017 and took on the leadership of the Core. Dr. Laura Herring joined the Core in 2023 to expand services to the Chapel Hill main campus and provide proteomics services in addition to mass spectrometry-based metabolomics. The Core specializes in using state-of-the-art metabolomics and exposome technologies to determine how molecules that are present in cells, tissues, and biological fluids are associated with weight status, nutrient status, and states of health and wellness. The measurement of perturbations in metabolism that arise from disease, dysfunction, or exposure (e.g., chemicals, drugs, nutrients, foods, stress) is referred to as metabolomics. The measurement of all exposures and the impact on endogenous metabolism is referred to as the exposome. Metabolomics is an ideal approach to assess the impact of nutrition and diet on health because individuals have different nutrient requirements and individuals respond differently to nutrient intake and diet and exercise interventions. The Core also provides metals assays and quantitative targeted analysis of metabolites involved in one carbon metabolism for nutrition and obesity studies. The Core’s services are unique and do not overlap with the North Carolina Translational and Clinical Sciences Institute (NC TraCS) or other UNC core services. The Core offers services and equipment at both the Chapel Hill main campus and the UNC Nutrition Research Institute campus (two hours from Chapel Hill in Kannapolis, NC) to make use of unique equipment and to broaden access to services for both UNC NORC members and external users. Modified Project Summary/Abstract Section – Clinical and Community Human Assessment and Interventions Core PI: Tate, Deborah F. Project Summary – Clinical and Community Human Assessment and Interventions Core. The Clinical and Community Human Assessment and Interventions (CHAI) Core is the primary resource at UNC for investigators to obtain services to support etiological and behavioral research in nutrition and obesity science. The Core collaborates with research teams to enhance their methodological and technical expertise to: 1) enable efficient and expert execution of behavioral and clinical assessment protocols (anthropometric, physical, and behavioral measures), and 2) facilitate the conduct of complex intervention studies. As a shared resource, the Core enables UNC NORC members and external users to efficiently add expertise to their team, often for a short or specific duration. The Core has a well-established infrastructure that accelerates human clinical, epidemiological, and intervention research in a seamless and cost-effective manner, and that assures that scientists use up-to-date, rigorous, and reproducible methods in their science. The behavioral assessment component of the Core offers methodological expertise and services to execute the assessment of diet and physical activity in human populations. These functions assure that scientists at UNC and other institutions use the latest cutting-edge methods in their research studies, including ActiLife software and the Nutrition Data System for Research (NDS-R®) and ASA24 (NCI). The clinical assessment component of the Core provides the expertise and equipment to support clinical measures for body composition using bioelectrical impedance, BodPod and DXA, depending on the needs of the investigator. Our clinical assessment facility is equipped for clinical metabolic assessments and is complete with a metabolic cart and whole room calorimetry, examination rooms, pharmacy, phlebotomy laboratory, specimen laboratory, furnished consultation rooms, as well as a metabolic kitchen to permit precise meal preparation and delivery for innovative studies of dietary composition. The intervention component of the Core has been providing services to researchers for 15 years to develop and conduct behavioral intervention research, qualitative research, and e-health and m-health intervention development. Specifically, the intervention component offers consulting and services in behavior change intervention and decision-aid websites and applications; logos and brochures, recruitment and presentation materials; user research, such as usability testing, qualitative interviews and focus groups; tailored messaging and feedback; and responsive design for mobile technology. The intervention component provides expertise in eHealth and mobile platforms and responsive web designs. Modified Project Summary/Abstract Section – Pilot and Feasibility Program MPI: Smith, Susan M. and Batsis, John A. Project Summary – Pilot and Feasibility Program. The Pilot and Feasibility (P&F) Program of the Nutrition Obesity Research Center (NORC) at the University of North Carolina at Chapel Hill (UNC) provides seed research support primarily for junior investigators in nutrition and obesity research during their critical transition years as new faculty members. The Program also provides seed research support to select established investigators whose previous expertise and research lie outside the UNC NORC research focus on nutrition and obesity, but whose proposals are sufficiently exciting and innovative to warrant UNC NORC support. Beyond the simple provision of research funding, the P&F program offers careful mentoring, supportive role models, and rigorous and consistent critiques of research projects. This comprehensive approach has resulted in a high return on investment in terms of federal- and non-federal external grant funding, high-impact publications, presentations, and career advancement. Since the inception of our P&F Program in 1999, the UNC NORC has awarded $2,737,229 to 68 unique investigators to support new and innovative research in nutrition and obesity. To date, P&F awardees have received $51,004,276 in external research support based on pilot data generated as part of their P&F projects. Most of this funding ($47,256,242) has been from the National Institutes of Health. The P&F Program continues to develop its research partnerships with nutrition and obesity research faculty at UNC as part of the Program’s effort to promote the career development of early career investigators. Modified Project Summary/Abstract Section – Enrichment Program MPI: Carroll, Ian Michael and Truesdale, Kimberly P. Project Summary – Enrichment Program. The Enrichment Program of the Nutrition Obesity Research Center (NORC) at the University of North Carolina at Chapel Hill (UNC) is designed to foster the exchange of knowledge and ideas among faculty members, trainees, research staff, and the community at large while increasing the general public’s awareness of nutrition and obesity research at UNC and beyond. These activities span basic science, epidemiologic research, intervention research, translational science, and nutrition- and obesity-relevant community engagement and policy. Activities include but are not limited to seminars, workshops, symposia for a variety of audiences, as well as nutrition education for physicians. The goals of the Enrichment Program are to create an engaging educational program to foster interdisciplinary collaborations, to provide training opportunities to foster the development of early career investigators and to educate the general public about the UNC NORC and the importance of nutrition and obesity research.